Genetic and Epigenetic Determinants of Longevity

Project Summary
Epigenetic regulation serves as a fundamental mechanism that bridges the genome with the
environment, and is a key determinant of longevity. C. elegans uses conserved modes of epigenetic regulation,
including histone modifications and non-coding RNAs, has a short normal lifespan and a vast toolkit for
molecular and genomic analyses, and represents a powerful model for unraveling the major principles of the
epigenetic basis of longevity. The long-term goal of this application is to elucidate how epigenetic regulation
bridges the genome and the environment to modulate aging. In this proposal, we build on original discoveries
made in our lab and will investigate the mechanistic connection between epigenetic regulation and longevity in
C. elegans using three specific aims. In Aim 1, we will investigate the mechanisms by which SET-26, a
H3K4me3 reader, regulates DAF-16 transcriptional activity. We recently revealed that SET-26 binds to the
histone modification H3K4me3 (histone 3 lysine 4 trimethylation) and requires DAF-16 to modulate stress
response and lifespan. In this aim, we will test whether recruitment to H3K4me3 sites in the genome is key for
SET-26 functions, and whether SET-26 collaborates with HCF-1 to regulate DAF-16 occupancy at target gene
promoters. Our study will illuminate how SET-26 links H3K4me3, a highly conserved histone modification, and
DAF-16, a highly conserved master transcription factor, in stress response and aging. In Aim 2, we will
elaborate the molecular characteristics and functional consequences of the unique patterns of histone
modification changes in aged C. elegans. Ongoing investigations in our lab have revealed interesting
patterns of histone modification changes in the somatic cells of aged C. elegans. Specifically, we observed a
combined pattern of low H3K36me3 and dynamic H3K4me3, two major histone marks associated with active
gene expression, to strongly correlate with RNA expression change with age. We will investigate whether this
unique pattern is tissue-specific, correlates with physiological aging, and reflects increased cryptic transcription
with age. We will also further characterize the observed gain of the repressive H3K27me3 and heterochromatin
H3K9me3 on particular chromosome arms with age. Our study will provide an invaluable resource for the
community and will point to the gene regulatory programs key to aging. In Aim 3, we will investigate the
epigenetic mechanisms of hormesis in aging. Hormesis in aging, where transient exposure to a mild stress
early in life can confer improved vitality later in life, is well known but much remains to be learnt about the
molecular basis of its long-lasting beneficial effects. We will compare two stress regiments that have been
demonstrated to increase stress resistance, improve proteostasis, and extend lifespan. We will investigate the
sustained transcriptional changes that confer the protective effects long after the initial stress exposure, and
the chromatin and transcription factors, and possible histone modifications, that regulate the transcriptional
memory.

Public health relevance
Project Narrative Epigenetic mechanisms refer to regulatory processes in cells and organisms that control heritable information other than the DNA sequence, and recent research has highlighted a key role of epigenetic regulation in determining how long an organism lives and whether that information is passed onto its offspring. This application proposes to use the powerful genetic model C. elegans to investigate the mystery of how epigenetic regulation influences longevity and its inheritance. The findings from this proposal will provide important insights into the basic biology of aging and may inspire future therapeutic development that aims to promote healthy aging and alleviate age-related diseases.